Stimulation combined with externally powered motorized orthoses for stroke

Objective - The objective of this study is to implement and test a neuro-mechanical gait assist (NMGA) device
to correct gait characterized by muscle weakness, incoordination or excessive tone in veterans with hemiplegia
from stroke that adversely affect their ability to walk, exercise, perform activities of daily living, and participate
fully in personal, professional and social roles.
Research Plan – Prototype NMGA device will be used to develop a finite state controller (FSC) to coordinate
user’s volitional effort coordinated with surface muscle stimulation and motorized knee assist as needed.
Brace mounted sensors will be used to develop gait event detector (GED) which will serve the FSC to advance
through the phases of gait or stair climbing. In addition, a supervisory rule-base intent detection algorithm will
be developed using brace mounted sensors and user interface input to select among various functions
including walking, stairs climbing, sit-to-stand and stand-to-sit maneuvers. The FSC controller tuning and
intent algorithm development and evaluation will be on three pilot subjects with gait deficits from stroke.
Outcome measures during development will provide specifications for a new prototype NMGA design which
will be evaluated on three pilot subjects to test hypothesis that NMGA improves walking speed, distance and
energy consumption of walking. These baseline data and device will be used to design a follow-up clinical trial
to measure orthotic impact of NMGA on mobility in activities of daily living at home and community.
Methodology – After meeting inclusion criteria, pilot subjects will undergo baseline gait evaluation with EMG
activities of knee flexors and extensors, ankle plantar and dorsiflexors and isokinetic knee strength and passive
resistance. They will be fitted with NMGA combining knee-ankle-foot-orthosis with motorized knee joint and
four channels of surface neuromuscular stimulation of plantar- and dorsi- flexors, vasti and rectus femoris.
Brace mounted sensor data will be used for gait event detector (GED) algorithm development and evaluation.
GED will serve FSC to proceed through phases of gait based on supervisory rule-based user intent recognition
algorithm detected by brace mounted sensors and user input interface. FSC will coordinate feed-forward
control of tuned stimulation patterns and closed-loop controlled knee power assist as needed to control foot
clearance during swing and stability of the knee during stance. Based on data attained during controller
development and evaluation, a new prototype NMGA will be design, constructed and evaluated on three pilot
subjects to test hypothesis that NMGA device improves safety and stability, increases walking speed and
distance and minimizes user effort. For all experimental conditions, a statistical power of 90% was used to
determine the number of repetitions required in the single subject design to detect statistically significant or
0.2m/s minimal clinically important improvement in walking speed.
Clinical Significance - The anticipated outcome is improved gait stability with improved swing knee flexion,
thus, increasing the safety and preventing injurious falls of ambulatory individuals with hemiplegia due to stroke
found in large and ever-increasing numbers in the aging veteran population. Correcting gait should lead to
improved quality of life and participation.

Public health relevance
Walking in stroke survivors is compromised by muscle weakness, lack of joint coordination or increased tone which causes toe dragging, poor stability, and increased risk of falls. Limited ability to walk can affect veteran’s work, social activities, role as a family member, ability to help others, religious and recreational activities and health benefits derived from walking. A novel neuro-mechanical gait assist combining bracing with motorized knee joint with surface stimulation will be implemented to improve walking. The expected gains for the veteran are improved quality of life, participation and health benefits derived from walking.